Interneuron circadian rhythms and tau-dependent network excitability in Alzheimer's disease pathogenesis

ABSTRACT
Alzheimer’s disease (AD) is the most common neurodegenerative disease, affecting more than 6 million
Americans. As AD only continues to increase in prevalence, new therapeutic approaches are needed to
combat this disease. A combination of clinical, neuroimaging, and neurophysiological studies have provided
converging evidence that network hyperexcitability, including mostly subclinical epileptiform activity, is an
important aspect of the early stages of AD. Many AD models exhibit similar network hyperexcitability that is
dependent on both APP/Aβ and tau. Because network hyperexcitability can potentially be targeted by a variety
of treatment approaches, a better understanding of the underlying mechanisms is needed. Circadian variation
is a prominent aspect of AD-related network hyperexcitability, which occurs mainly during the inactive phase in
both AD patients and mouse models. Emerging data from both human and animal models indicate that neural
excitability is under circadian control. Diurnal changes in inhibition may drive this, as there is a relative increase
in levels of cortical inhibition during the inactive phase corresponding to lower cortical excitability. Parvalbumin-
positive (PV) interneurons are one of the most abundant interneuron types in the hippocampus and cortex;
however, they are one of the multiple subtypes of inhibitory interneurons derived from the medial ganglionic
eminence that interact to maintain cortical network dynamics. Preliminary data suggests altered clock gene
expression in PV interneurons, increased epileptiform activity, and behavioral disinhibition in the hAPPJ20
model. Many important questions remain, including the functional and molecular mechanisms in MGE-derived
inhibitory interneurons that contribute to circadian- and tau-mediated EA in AD models with increased levels of
APP/Aβ. Thus, the current proposal will test the novel concept that circadian rhythms in cortical MGE-derived
interneurons play a critical role in modulating network excitability and behavior. My overarching hypothesis
is that altered clock gene rhythms in MGE-CINs contribute to network hyperexcitability and behavioral
abnormalities, which can be corrected by tau reduction. I will test this hypothesis using single-molecule
fluorescent in situ hybridization to quantify clock-gene transcript expression, electroencephalography to assess
network hyperexcitability, and machine learning pipelines to analyze open-field videos for behavior. For these
studies I will use hAPPJ20 mice, a commonly used model of AD with overexpression of APP & Aβ crossed
with Tau+/- mice for my experimental groups for Aim 1. I will use Lhx6-Cre mice crossed with Bmalfl/fl to create a
line of mice with the circadian clock ablated in only cortical MGE-interneurons, which will then again be
crossed with Tau+/- for Aim 2 experiments. Overall, the work proposed will provide insights into the circadian
mechanisms driving network hyperexcitability and behavioral changes in AD.

Public health relevance
PROJECT NARRATIVE Epileptiform activity (EA), primarily during the inactive circadian phase, is a common feature of Alzheimer’s disease (AD) and is associated with increased cognitive decline and mortality. Inhibitory interneurons are critical for maintaining network inhibition and likely underlie the diurnal expression of EA in AD. Preliminary data implicates Parvalbumin interneurons derived from the medial-ganglionic eminence (MGE) as critical for network excitability; therefore, this proposal will investigate the unknown mechanisms of clock-gene expression across all cortical MGE-interneuron cell types and their contribution to tau-mediated EA in AD.